Molecular Mechanisms of Insulin Resistance Associated Loci

PROJECT SUMMARY
Insulin resistance (IR) is necessary for the development of type 2 diabetes (T2D) and is a major cardiovascular
diseases risk factor. IR has few therapeutic options and identification of new drug targets and novel IR
mechanisms would have a huge impact on public health. Although genome wide association studies (GWAS)
have identified hundreds IR-associated genetic loci, there has been limited progress towards identifying causal
genes and mechanisms.
Our colocalization analysis combined data from GWAS of IR-associated traits (T2D, fasting insulin, fasting
glucose, waist-hip ratio adjusted for body mass index, triglycerides and high-density lipoprotein cholesterol)
and expression quantitative trait loci (eQTL) within five tissues related to IR or T2D (subcutaneous and visceral
adipose tissue, skeletal muscle, liver and pancreas). The analysis identified specific causal IR genes in about
25% of IR loci and in half of these cases, the effects are attributable to effects in adipose tissue.
We will extend our findings through larger colocalization studies and use single cell data to identify a credible
list of adipose cell specific IR causal genes (Aim 1). In Aim 2, we will functionally characterize IR causal genes
for cellular mechanisms of action as well as define gene regulatory networks by employing single cell analyses
of transcriptomes and epigenomes following CRISPR gene perturbation. In Aim 3, we will define the
physiological role of causal genes in vivo by creating loss of function mouse models by combining a CRISPRi
mouse with the delivery of sgRNA and Cre recombinase via the adipose tissue specific AAV delivery system.
By combining human genetics, computational analysis, and functional genomics tools, we will establish causal
genes and their mechanisms of action in development of IR. This effort will lead to novel mechanisms and
drugs targets to address the unmet need posed by IR, T2D and cardiovascular disease.

Public health relevance
PROJECT NARRATIVE Insulin resistance (IR) is a common and increasing health problem that precedes development of type 2 diabetes and causes cardiovascular disease, but its genetic determinants are largely unknown. We will combine innovative methods including colocalization studies followed by single cell transcriptomics and single cell epigenomics to establish causal genes and mechanisms of action for novel genes involved in development of IR, and validate the physiological role of causal genes in vitro and in vivo using mouse models in a fat-depot specific way. Our work will lead to mechanistic insights into the development of IR and to better treatments for IR and related conditions.